Function, evolution and engineering of proteins

Project Summary
The sequence-function landscape of a protein is the connection of genotype and phenotype at a
molecular level. Although abstract, this concept has many real-world applications. Mapping and
predicting this space would improve our basic science understanding of macromolecular function in the
cell, clarify the role of genetic variation in causing disease, and lead to our ability to design biological
therapeutics with improved potency and specificity. The goal of our work is to develop experimental
methods to systematically explore the mutational landscape of biomedically relevant proteins such as
CRISPR-Cas genome editing enzymes. A related aspect of our work is to create new types of assays
that yield robust measurements of real biochemical parameters, rather than relative measurements which
are typically measured out of convenience. In the long term, our goal is to couple this data, mechanistic
studies, and machine learning tools to develop state of the art methods for predicting and engineering
protein function.

Public health relevance
Project Narrative The goal of our work is to develop experimental methods to systematically explore the mutational landscape of biomedically relevant proteins. In the long term, such methods will improve our basic science understanding of macromolecular function in the cell, clarify the role of genetic variation in causing disease, and lead to the design biological therapeutics with improved potency and specificity.